Emergence of polycystic ovary syndrome (PCOS) during adolescence

PROJECT SUMMARY. Polycystic ovary syndrome (PCOS) affects 1 in 8 women of reproductive age imparting
reproductive, cardiometabolic and psychological health complications for patients across the lifespan. PCOS is
defined by the presence of 2 or more cardinal features including ovulatory dysfunction, hyperandrogenism and
polycystic ovarian morphology (PCOM). Although PCOS manifests during adolescence, delays in diagnosis
are common as the cardinal features are said to overlap with characteristics of the normal adolescent
reproductive transition. Current standards to define PCOS in adolescence differ from those in adulthood – they
do not include PCOM owing to a lack of data. This exclusion results in a narrow spectrum of PCOS during
adolescence which may not fully capture all with PCOS until 8y post-menarche when adult-criteria for PCOM
are available. Our preliminary data support that ovarian morphology has diagnostic accuracy for PCOS in
adolescents and reflects the severity of reproductive and metabolic symptoms in a manner similar to adults.
Further, in a longitudinal pilot evaluation of ovarian morphology in healthy adolescents, we show that ovarian
markers in the first post-menarcheal year, including anti-Müllerian hormone, predict persistent menstrual cycle
irregularity at 2y post-menarche suggesting that morphologic indicators precede in the timeline to aberrant
reproductive maturation. We propose that an understanding of the natural history of PCOS during adolescence
can provide a framework for the earliest detection and mitigation of this highly prevalent disorder. To that end,
this project will define the trajectory of PCOS symptoms during early adolescence (Aim 1) and develop a
nomogram of ovarian form and function during the first 8 gynecological years (Aim 2). Our approach involves
elucidating the time course of divergences in ovarian morphology, androgen concentrations and menstrual
cyclicity in adolescent cohorts who develop PCOS versus those who establish regular menstrual cycles in the
first 3y post-menarche. Further, we will conduct a cross-sectional analysis of sonographic and serum markers
of PCOM across gynecological ages <1y– 8y in order to define PCOM during this developmental period. The
hypotheses to be tested are that changes in ovarian morphology that occur in association with the
establishment of regular menstrual cycles differ from those seen in adolescents with persistent cycle
irregularity, hyperandrogenism and/or PCOS, and that early and distinct aspects of ovarian morphology predict
the likelihood of PCOS in early gynecological life. By defining the normal limits of ovarian form and function
during adolescence, we also expect to generate developmental-stage specific criteria for PCOM that reveal the
actual clinical spectrum of PCOS during this life stage. This research will immediately improve diagnostic
experiences for patients and families by resolving the ambiguity related to the role of ovarian morphology in the
early detection of PCOS. Likewise, a new understanding of the emergence of PCOS in adolescence will usher
opportunities for the timely intervention, and possible prevention, of this major problem in women’s health.

Public health relevance
PROJECT NARRATIVE. This project will establish the trajectory of polycystic ovary syndrome (PCOS) symptomology during adolescence, and provide the appropriate criteria needed to define polycystic ovarian morphology (PCOM) during this developmental window. By defining divergences in normal ovarian form and function during the initial post-menarcheal years, this project will reveal early and non-invasive biomarkers of PCOS and provide a definitive basis for the inclusion of ovarian morphology in the phenotypic spectrum of adolescent PCOS. Together, the findings of this research will address a critical knowledge gap related to the natural history of PCOS and enable strategies for the early detection, and potential prevention, of this highly prevalent and enigmatic condition.